Regulation of rodent energy metabolism, body weight and composition

Our laboratory continues to develop mathematical models of mouse energy metabolism and body weight dynamics. Recently, we helped quantify the so-called "thermoneutral zone" and the energy cost of physical activity in mice. These projects are being pursued in collaboration with Dr. Marc Reitman's laboratory in the Diabetes Endocrinology and Obesity Branch and will provide an improved understanding of the regulation of energy metabolism in mice and their similarities and differences with humans. We also collaborated with Dr. Barbara Rehermann's laboratory to better understand energy expenditure differences in conventional laboratory mice as compared to "wildling" mice whose guts have been populated by microbiota from wild mice.